HBV replication and persistence in mouse models

DESCRIPTION (provided by applicant): Hepatitis B virus (HBV) is a hepatotropic virus that can cause severe liver diseases including acute and chronic hepatitis and hepatocellular carcinoma (HCC). There are ~350 million people in the world that are chronically infected by this virus, resulting in 0.5-1 million deaths every year. HBV has a very narrow host range, which has greatly hampered its research. The development of several mouse models in recent years, however, has partially overcome this problem and generated many important findings for understanding HBV replication and pathogenesis. By crossing female hemizygous HBV transgenic mice to male naïve mice, we were able to obtain non-transgenic mouse pups. When these non-transgenic mouse pups were injected with the HBV genomic DNA by hydrodynamic injection, the HBV replication persisted in the mouse liver for up to seven months, resembling the vertical transmission of HBV in patients. Clinically, over 90% of babies born to women who are HBV carriers will become HBV carriers. This vertical transmission is the most common way of HBV transmission, particularly in HBV endemic areas, and the most important reason for chronic HBV infection. Our mouse model thus provides us with a unique opportunity to study the mechanism of HBV persistence after vertical transmission. We will use this mouse model to investigate the role of the HBV e antigen (HBeAg), which is thought to play a very important role in establishing persistent infection after the vertical transmission, and a class of HBV mutants, which carry a double-nucleotide mutation in the basal core promoter (BCP) and have a reduced expression level of HBeAg, in HBV persistence and pathogenesis. In addition, our recent studies indicated that HBV persistence could also be affected by the size of viral inoculums and interferons α and β (IFN-α/β). Thus, we will also investigate the role of these factors in HBV persistence. Our proposed research will provide important information for us to understand HBV replication and persistence and facilitate the development of treatments for HBV patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: Hepatitis B virus (HBV) is an important human pathogen. There are approximately 1.2 million people in the U.S. that are chronically infected by this virus. Many of these patients will develop severe liver diseases including liver cirrhosis and liver cancer and will require liver transplantation for survival. The goal of our proposed research is to use a mouse model to understand the replication cycle of HBV and how it establishes persistent infection. Our research will improve our knowledge about this important pathogen and lead to the improvements of treatments for HBV patients. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Hepatitis B virus (HBV) is a hepatotropic virus that can cause severe liver diseases including acute and chronic hepatitis and hepatocellular carcinoma (HCC). There are ~350 million people in the world that are chronically infected by this virus, resulting in 0.5-1 million deaths every year. HBV has a very narrow host range, which has greatly hampered its research. The development of several mouse models in recent years, however, has partially overcome this problem and generated many important findings for understanding HBV replication and pathogenesis. HBV transgenic mice that carry the 1.3mer over-length HBV genome productively replicate HBV in the liver and resemble asymptomatic HBV carriers. The hydrodynamic injection is another procedure that has been used to introduce the HBV genomic DNA into the mouse liver to direct HBV replication in vivo. Mice injected with the HBV DNA via this procedure will develop immune responses against HBV and clear the virus after three weeks. Thus, the hydrodynamic injection creates a scenario that resembles acute HBV infection in patients. By combining these two mouse models, we have recently developed a non- transgenic mouse model for persistent HBV replication. Clinically, over 90% of babies born to women who are HBV carriers will become HBV carriers. This "vertical transmission" is the most common way of HBV transmission and the most important reason for chronic HBV infection. By crossing female hemizygous HBV transgenic mice to male naïve mice, we were able to obtain non-transgenic mouse pups. When these non- transgenic mouse pups (i.e., "Tg-derived HBV-negative (TGD) mice") were injected with the HBV genomic DNA by hydrodynamic injection, the HBV replication persisted in the mouse liver for up to seven months, resembling the vertical transmission of HBV in patients. This mouse model provides us with a unique opportunity to study the mechanism of HBV persistence. Based on this mouse model as well as our recent findings that the size of viral inoculums and interferons α and β (IFN-α/β) could affect HBV persistence, we propose the following aims: Aim 1. Mechanism of HBV persistence after vertical transmission Although the vertical transmission of HBV frequently leads to chronic HBV infection, the horizontal transmission (i.e., between adults) usually leads to only self-limited acute infection. In this aim, we will use the mouse model that we have established to understand the mechanism of HBV persistence after the vertical transmission. Aim 2. Role of HBeAg in HBV persistence in Tg-derived HBV-negative (TGD) mice The HBV C gene encodes the core protein and the precore protein, which are two related proteins. The core protein forms the viral core particle (i.e., HBV core antigen, HBcAg) and the precore protein is the precursor of the HBV e antigen (HBeAg) found in the serum of HBV patients. HBeAg is not essential for HBV replication. However, if the mother is HBeAg-positive, her babies will invariably become chronic HBV carriers if not treated. In contrast, if the mother is HBV DNA positive and HBeAg-negative, her babies will mostly develop only acute infection. The goal of this aim is to use our mouse model to determine the role of HBeAg in the vertical transmission of HBV. Aim 3. The BCP mutant in HBV persistence and pathogenesis The expression of the HBV C gene is controlled by the basal core promoter (BCP). A double-nucleotide mutation of G→A at nt. 1762 and A→T at nt. 1764 in the BCP is frequently found in HBV patients with chronic hepatitis symptoms. This double mutation reduced the expression level of HBeAg without affecting the expression of the core protein. The goal of this aim is to understand how the reduced expression level of HBeAg of this BCP mutant affects HBV persistence and pathogenesis. Aim 4. Inoculum size and interferons on HBV persistence Recent studies indicated that a small viral inoculum size would favor HBV persistence whereas a large inoculum would favor viral clearance. In addition, in our recent studies, we found that the depletion of IFN-α/β would shorten the duration of viral persistence in mice when the viral level was low, suggesting a role of IFN- α/β in enhancing viral persistence. The goal of this aim is to understand whether different inoculums sizes elicit different immune responses and how IFN-α/β affect HBV replication and persistence.